The Role and Therapeutic Targeting of GPR56 in Colorectal Cancer

ABSTRACT:
Colorectal Cancer (CRC) remains the second leading cause of cancer-related deaths as current treatments for
advanced disease have been limited by low response rates and adverse side-effects. Failure of treatment is
attributed to tumor heterogeneity and the presence of cancer stem-like cells (CSCs). Plasticity of CSCs has been
shown to drive therapy resistance and metastasis. Identifying novel targets involved in plasticity and disease
progression is important for the development of more effective therapies. GPR56, a member of the adhesion G
protein-coupled receptor family, is highly expressed in a large fraction of CRC and is associated with poor
prognosis. We showed GPR56 increased resistance to chemotherapies and promoted tumor growth in mouse
models of CRC. GPR56 is upregulated with loss of the CSC marker LGR5, suggesting a role in plasticity. Our
group has generated unique GPR56 monoclonal antibodies (mAbs) that can be used to investigate GPR56
function and for the development of antibody-drug conjugates (ADCs). The objectives of this project are to
identify the role and signaling mechanisms of GPR56 in disease progression and resistance and to develop and
evaluate unique GPR56-targeted ADCs and combination therapies for the improved treatment of CRC. In Aim
1, patient-derived organoids will be used to characterize the role and signaling mechanism of GPR56 in colorectal
CSCs and metastasis. In Aim 2, we will develop highly potent GPR56 ADCs and evaluate tolerability and efficacy.
Phage display and immunoPET will be used to improve GPR56 mAb affinity and select leads for ADC
development, respectively. Optimized GPR56 ADCs will be generated with different linker-payloads using site-
specific conjugation and evaluated for antitumor efficacy in syngeneic and patient-derived xenograft models. In
Aim 3, we will assess an ADC dual-targeted approach to overcome therapy resistance and metastasis. GPR56
ADCs will be tested alone and in combination with other CSC-targeted therapies for the prevention and treatment
of metastasis using orthotopic models. The proposed study presents an opportunity to reveal novel functions for
GPR56 in CRC and develop unique ADCs and dual-targeted strategies to potentially overcome resistance and
metastasis.

Public health relevance
PROJECT NARRATIVE: Colorectal cancer (CRC) continues to be a leading cause of cancer-related death, as advanced and metastatic disease responds poorly to current therapies. Therefore, the identification of new targets and therapeutic approaches is essential to improve patient outcomes. This project aims to elucidate the function of a novel drug target GPR56 in metastasis and develop and evaluate unique antibody-drug conjugates as new and improved therapies to treat CRC and potentially other cancers.